Reprogramming tumor-reactive CD8 T cells by targeting the IL-21-BATF pathway to treat melanoma

Project Summary
Advanced melanoma is a major target of cancer immunotherapy research due to its poor survival rate even
with recent treatment advances. Current strategies focus on CD8 T cells which enter a dysfunctional state in
the tumor microenvironment. Recent studies have found that intratumoral CD8 T cells consist of a
heterogeneous population of memory-like progenitor, effector and terminally exhausted cells that exhibit
differing functional and self-renewal capacities. However, the cellular and molecular processes involved in the
differentiation of these subsets within melanoma is not well understood. Exploring the intricacies of CD8 T cell
differentiation towards an effector profile can identify novel immunotherapeutic targets. Thus, the long-term
goal of this project is to elucidate the mechanisms regulating effector CD8 T cell differentiation and
function in melanoma.
CD4 T cell production of cytokines provide help to CD8 T cells. Recent studies have uncovered the cytokine IL-
21 as a critical signal produced by CD4 T cells to help promote CD8 T cell maintenance in chronic infection.
However, the direct effects of IL-21 produced by CD4 T cells on CD8 T cell differentiation and function in
cancer remains unknown. Preliminary data presented in this proposal suggest that IL-21 producing CD4 T cells
induce an effective antitumor response dependent on CD8 T cells. Additionally, it has been previously found
that IL-21 signaling induces the transcription factor BATF, which is known to cooperatively bind with IRF4 to
induce changes in the chromatin landscape. This has led to the hypothesis that the IL-21-BATF pathway
enhances melanoma-infiltrating effector CX3CR1+ CD8 T cells and their function via BATF-IRF4
mediated transcriptional regulation.
Aim 1 will determine if adoptively transferred IL-21-producing CD4 T cells enhance effector CX3CR1+
CD8 T cell differentiation. The effect of CD4 T cell-derived IL-21 on CD8 T cell differentiation and function will
be determined in vivo. Then, it will be determined if IL-21R signaling is intrinsically necessary for the CD8 T cell
response to IL-21 producing CD4 T cell help.
Aim 2 will investigate the mechanism of BATF-mediated tumor-infiltrating CD8 T cell differentiation.
These experiments will determine if BATF-IRF4 interaction is necessary to promote tumor-infiltrating CX3CR1+
CD8 T cells. Furthermore, changes in BATF-mediated chromatin accessibility in CD8 T cell differentiation and
function will be assessed.
This proposal will help in understanding how CD8 T cells differentiate and function in melanoma. This is in line
with the mission of NCI, as the results of this project could lead to the identification of BATF as a novel
therapeutic mechanism to enhance effector CD8 T cell differentiation to fight cancer.

Public health relevance
Project Narrative Advanced melanoma remains resistant to treatment; therefore, recent cancer immunotherapy research aims at enhancing the immune response against cancer. The cytokine IL-21, produced by CD4 T cells, may play a critical role in promoting functional effector CD8 T cells and preventing their exhaustion. Thus, the overall goal of this project is to dissect the mechanism by which CD8 T cells limit exhaustion and promote antitumor function, as this can help to identify novel cancer therapeutics.